Regulation of the Tryptophan Hydroxylase-2 Promoter by Estrogen

DESCRIPTION (provided by applicant): Ovarian Hormones, such as estrogen, are thought to play a significant role in regulation of affective disorders. This may occur through modulation of serotonin (5-HT) system emanating from the midbrain dorsal raphe nucleus (DRN). In support of this hypothesis, we have found that chronic estradiol (E2) treatment in ovariectomized rats increases the expression of tryptophan hydroxylase-2 (TpH2), the rate-limiting enzyme for 5-HT biosynthesis, selectively in the caudal DRN and this increase is critical for the anxiolytic effects of E2. E2- induced increases of TpH2 mRNA are mediated via estrogen receptor beta (ER2), and activation of local ER2 in the DRN is sufficient for this increase in TpH2 mRNA and for antidepressant effects of E2. As ER2 is found on serotonergic neurons in the caudal DRN, these studies lend credence to the hypothesis that E2 acts directly on the 5-HT neurons to increase TpH2 mRNA via ER2. However, exact mechanisms underlying this E2 effect on TpH2 are yet to be elucidated. Therefore, the proposed study will investigate the overarching hypothesis that that estrogen increases TpH2 mRNA directly via ER2, and address the possibility that estrogen activates the transcriptional region of the TpH2 promoter via interaction with ER2 and its co-regulator proteins. We will test this idea by first examining the functional effects of estrogen interaction with ER2 on the TpH promoter-luciferase construct using reporter gene assay in vitro. Second, we will identify the regulatory regions of the estrogen and ER2 induced activation of the TpH2 promoter by using progressive 5'deletions of the TpH2 promoter, followed by site directed mutagenesis of potential regulatory elements. Finally, we will explore the array of possible co- regulatory factors and mechanisms involved in ER2 mediated activation of TpH2 by using chromatin immunoprecipitation assay, triple labeled immunohistochemistry and antisense oligonucleotide knockdown. PUBLIC HEALTH RELEVANCE: The proposed study will elucidate the genetic and molecular mechanisms underlying the interaction between estrogen receptor beta and the tryptophan hydroxylase 2 (TpH2) gene promoter. This interaction activates gene expression of the rate-limiting enzyme for serotonin biosynthesis, TpH2, which has been implicated in the etiology of affective disorders. This study will address the possibility that estrogen regulates TpH2 expression through direct interactions of estrogen receptor with distinct regulatory regions of the TpH2 promoter. Understanding the exact mechanisms of the estrogen regulation of this gene may lead to novel targets for treatment of affective disorders in women.

Public health relevance
The proposed study will elucidate the genetic and molecular mechanisms underlying the interaction between estrogen receptor beta and the tryptophan hydroxylase 2 (TpH2) gene promoter. This interaction activates gene expression of the rate-limiting enzyme for serotonin biosynthesis, TpH2, which has been implicated in the etiology of affective disorders. This study will address the possibility that estrogen regulates TpH2 expression through direct interactions of estrogen receptor with distinct regulatory regions of the TpH2 promoter. Understanding the exact mechanisms of the estrogen regulation of this gene may lead to novel targets for treatment of affective disorders in women.